Immunologic Dysfunction in Biliary Atresia

PROJECT SUMMARY/ABSTRACT
Biliary atresia is the most common cause of end-stage cirrhosis in children and the number one indication for
pediatric liver transplantation. It results from an inflammatory and fibrosing obstruction of extrahepatic bile
ducts that presents as neonatal jaundice. Despite prompt diagnosis and surgical treatment, the disease
progresses and causes substantial morbidity and mortality. Although the etiology remains largely undefined,
studies pursuing the previous aims of this award have advanced knowledge of pathogenic mechanisms of
disease. Specifically, we uncovered a sequential activation of the innate and adaptive immune systems, with a
prominent type-1 inflammatory response that targets the cholangiocytes and promotes epithelial injury.
Consistent with a multifactorial basis of disease, we also found type-2 signals and directly linked them to a
novel paracrine circuit involving lineage-negative (Linneg) cells functionally committed to type-2 innate lymphoid
cells (ILC2s) that secrete soluble mitogenic factor(s) to neighboring cholangiocytes. In this competing renewal
application, we provide substantial preliminary data that forms the rationale for a unifying hypothesis that novel
immature immune cells in the liver and bile ducts have dual roles as regulators of the immune response and
the source of survival signals. This hypothesis will be tested in three closely related but independent aims. In
Aim 1, we will investigate how ILC2s use amphiregulin (Areg) to promote epithelial repair in bile ducts. This will
be done by validating initial findings that Areg induces cholangiocyte proliferation in vivo, the molecular
mechanisms of growth, and how Areg signaling protects neonatal mice against the virus-induced phenotype of
biliary atresia. In Aim 2, we will define the tissue population by Linneg cells and their roles in epithelial
proliferation. This aim builds on initial experiments using single-cell sequencing strategies that show the
functional commitment of Linneg cells based on their population of the hepatic or biliary environments. Following
validation of these cells using complementary technologies, we will directly examine how novel bile duct-
resident BIM cells and their expression of IL-6 regulate cholangiocyte proliferation and epithelial injury in
experimental biliary atresia. And in Aim 3, we will determine how Linneg CR71+ cells that exist in extramedullary
hematopoietic cells that reside in the neonatal liver promote biliary atresia. Based on preliminary data, we
propose studies to explore their role as a susceptibility factor for experimental biliary atresia, and to investigate
the mechanisms they use to quench the inflammatory response of neonatal myeloid and NK cells. Upon
completion, the proposed experiments will advance our understanding of the pathogenic mechanisms of
disease and uncover new cell groups and molecular signals that promote repair of the injured tissue, thus
identifying potential targets for new therapies to block progression of disease and foster long-term survival of
patients with biliary atresia.

Public health relevance
PROJECT RELEVANCE/NARRATIVE This project studies biliary atresia, the most common cause of chronic liver disease in children and the leading indication for pediatric liver transplantation in the United States. We propose to investigate how the neonatal immune system has a dual role as promoters of bile duct injury and as suppliers of survival signals to restore integrity of the epithelium. These survival signals come largely from newly identified cells that secrete growth factors to restore the integrity of the biliary epithelium. The proposed studies will identify novel therapeutic targets to block progression of liver disease and foster improved outcome of children with liver disease.